Prosocial Behavior and Volunteerism to Promote Physical Activity in Older Adults

DESCRIPTION (provided by applicant): The long-term objectives of this research project are (1) to determine the effects of three interventions on physical activity and other health outcomes at 12 months post-randomization among 300 sedentary and underactive older adults aged 55 to 80 years, and (2) to determine whether prosocial behavior is a construct that can be successfully implemented within Social Cognitive Theory. Based upon our preliminary study, we have designed a prosocial behavior physical activity intervention that will incorporate opportunities to aid the Second Harvest Food Bank of Northwest North Carolina based upon weekly physical activity. Along with the established benefits associated with physical activity, the

Public health relevance
public health relevance of this project relates to the fact that it will continue collaborations with the William G. White, Jr. YMCA and Lowe's Foods, which are two well-known, regional organizations with long-standing reputations for community service. This study is designed as a three-arm randomized controlled trial. The three 12-month interventions include (1) a "healthy aging" control intervention that is based largely on educational sessions; (2) a standard "physical activity" intervention that involves structured, group-mediated physical activity sessions coupled with cognitive- behavioral counseling; and (3) the prosocial behavior physical activity intervention, which includes the components of the physical activity intervention plus the prosocial behavior incentive. The primary aims of the study are to compare the effects of the three interventions on 12-month levels of physical activity, physical function, and health-related quality of life. We will also assess whether these outcomes are mediated by changes in constructs from Social Cognitive Theory, and whether changes in Social Cognitive Theory constructs are associated with changes in prosocial behavior. Regular physical activity is beneficial to promoting health. However, most adults do not engage in regular physical activity at levels recommended by health professionals. Therefore, the purpose of this study is to determine whether prosocial behavior, defined as voluntary behavior that benefits others, can be used to help people to begin and continue a regular physical activity program. __SpecificAimsTextDelimiter__ 2. Specific Aims Despite overwhelming evidence of the benefits of regular physical activity upon health outcomes for older adults1, it is a distressing fact that regular physical activity rates have remained quite low in this population. Indeed, it is estimated that approximately 50% of adults who begin an exercise program will discontinue within the first 6 months2. The urgency of these issues is compounded in light of estimates that the number of US adults aged 65 years or older will increase from 40 million in 2010 to 70 million in 2030. Several studies3, 4 have demonstrated that traditional methods for physical activity prescription can be coupled with cognitive- behavioral strategies to facilitate long-term activity; however, developing novel, effective strategies to promote physical activity will continue to be of prime importance to maintain and improve health in this population. One novel behavior change strategy may entail providing older adults with long-term opportunities to aid other individuals or causes through regular physical activity. In naturalistic settings, episodic events such as "charity fun events" are purposely designed to combine physical activity with prosocial behavior, defined as "voluntary, intentional behavior that results in benefits for another"5 Usually, these events draw participants from a large range of fitness, age, and socioeconomic categories, and generate considerable publicity from the local and national media. For example, the American Heart Association estimates that its yearly event Walk for Heart will draw more than 1 million walkers in 2010. There is an abundance of other such events that are held yearly across the United States, such as the Arthritis Foundation's Arthritis Walk and the Susan B. Komen Race for the Cure. Other events employ other forms of physical activity, such as golfing. Although the focus of these events is fundraising, it is intriguing that these activities inspire large numbers of individuals to participate in a single physical activity session. Many of these individuals return to an underactive lifestyle after the event. Thus, an interesting, yet largely unexplored research question concerns whether prosocial behavior may be successfully and sustainably incorporated into programs to promote long-term physical activity. Consideration of these issues, along with our R21 pilot work (Section 3.F.1) have led our experienced team to propose a R01 longitudinal study among adults aged 55 to 80 years. We plan to conduct a randomized controlled trial to assess the effect of a physical activity intervention that incorporates prosocial behavior upon physical activity at 12 months post-randomization as compared to either a standard physical exercise intervention or a healthy aging education program. We will randomize 300 participants, aged 55 to 80 years, into either a prosocial behavior physical activity (PBPA; n=100), standard physical activity (PA; n=100) or healthy aging (HA; n=100) intervention. Below, we describe our specific aims and their associated hypotheses. Aim 1: Our primary aim is to determine the efficacy of the PBPA, PA, and HA interventions on physical activity at 12 months in men and women aged 55 to 80 years (Section 3.C.3.a.). Hypothesis: The PBPA intervention will demonstrate greater levels of physical activity at 12 months compared to those in the PA or HA groups. Aim 2: To determine the impact of the three interventions upon physical function (Section 3.C.3.b). Hypothesis: The PBPA intervention will demonstrate more favorable scores on validated physical performance tests at 12 months compared to the other two groups; Aim 3: To determine the effect of the three interventions upon health-related quality of life (HRQL). We will assess several HRQL dimensions, including depressive symptoms, perceived stress, exercise-related affect, and sleep quality (Section 3.C.3.c). Hypothesis: The PBPA intervention will report more favorable HRQL compared to the PA and HA interventions. In this project, we will continue our successful collaborations from our previous pilot project with the William G. White Family YMCA and Lowe's Foods. In addition, we will use both qualitative and quantitative approaches in our development and implementation of the PBPA intervention. The PBPA intervention itself is based upon Social Cognitive Theory6, a well-established theory of behavioral change. If successful, this study may suggest that prosocial behavior is associated with constructs in Social Cognitive Theory, which would be a novel finding. Moreover, this intervention may have public health significance, and could serve as a model for dissemination across the country to enhance physical activity, physical and psychological wellness, and social benefit.